Protein Disorder as a Mechanism of RNA Binding and Regulation

Project Abstract
(same as Parent R35GM142864)
As factors involved in all aspects of RNA processing, RNA binding proteins (RPBs) are master regulators of
gene expression. Despite this critical role, gaps remain in our understanding of how RBPs interact with RNA.
Generally, RBPs have been considered to interact with typically single-stranded RNA via folded RNA-binding
domains. However, many RBPs also have inherently disordered domains of low compositional complexity (low
complexity domains, LCDs). In our current understanding of how RBPs interact with RNA, LCDs mediate protein-
protein interactions and/or weak, non-specific RNA interactions. In contrast, a growing body of literature, and our
own data, indicate LCDs are capable of specific binding to highly stable guanine-based helical RNA structures.
These findings represent a reversal of the canonical binding mode: rather than folded protein binding to
unstructured RNA, we have observed folded RNA binding to unstructured protein. My research program asks i)
how do RBP LCDs interact with RNA? And, ii) what are the functional consequences of LCD-RNA interactions?
This proposal outlines my research program to decipher basic mechanisms and dynamics of RBP-RNA
interactions and define their role in normal and pathogenic pathways combining unbiased biochemical
approaches with cell-based genomic strategies. Data generated from the proposed research will contribute
broadly across all areas of cell biology by illuminating a more complete picture of RBP-RNA interactions.

Public health relevance
Project Narrative RNA-protein interactions are essential for gene regulation and often disrupted in disease. However, we know relatively little about how RBPs select their RNA targets. This administrative equipment supplement to award R35GM142864 will further enable us to better define mechanisms of RNA-protein interactions that have important implications for normal and disease biology.